Top-down mechanisms and modulation of flexible tactile discrimination

ABSTRACT
In contrast to fixed stimulus-response associations, flexible behavior allows organisms to respond differently to
the same stimuli depending on their current goals. Given a relatively stable structure of the brain, how can
organisms implement different stimulus-response associations in a context-dependent, goal-directed manner?
While previous work has investigated the roles of various brain regions in flexible switching behavior, we still lack
fundamental understanding of how neural signals propagating within and between brain regions underlie this
important cognitive function. Our proposal focuses on the interactions between three different brain regions in
mediating rule switching: the locus coeruleus, the orbitofrontal cortex, and the somatosensory cortex. We test
specific hypotheses regarding the contributions of each of these circuits by combining pathway-specific
perturbations with cellular-resolution neurophysiological recordings in task-performing mice. Altogether, we will
provide a unifying framework for how the locus coeruleus, orbitofrontal cortex, and somatosensory cortex
coordinate to implement flexible goal-directed behavior.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health and NIH’s mission, because LC-NE and frontal cortices are implicated in many neurological diseases, including aging-, attention- and anxiety- related disorders. Insights gained here are a pivotal step toward explaining how these circuits are involved in higher cognitive processes, potentially facilitating the studies of neurological disorders in non-human primates and humans.